Administrative Core

Administrative Core Summary
An efficient administrative structure is essential to the design and implementation of the TUCAIN U54 Center.
The Admin Core will be focused on facilitating communication, collaboration, planning, data sharing, and
scientific and financial oversight of the Shared Resource Cores and Research Projects within TUCAIN. Through
the Admin Core, we will oversee all the goals of the Center and ensure their successful, cost-effect, and timely
completion. The Admin Core will coordinate, schedule, and implement monthly internal teleconferencing
meetings among the Center participants, and will assist the PIs of the Cores and Projects in the preparation of
progress reports, internal compliance filings, and manuscripts to support the overall goals of TUCAIN.
The Admin Core will be responsible for the following Specific Aims: (1) Create an administrative, communication
and leadership structure for TUCAIN. (2) Provide an effective and responsive line of communication between
TUCAIN members, the NIH, and other members of SeroNet. (3) Ensure the full integration of Projects and Cores
within TUCAIN. (4) Assist Core and Project PIs with administrative aspects. (5) Communicate with other
members of SeroNet to facilitate collaboration and coordination. (6) Provide each Core and Project under
TUCAIN with robust, integrated data management and statistical support. (7) Coordinate periodic evaluation of
TUCAN and engage the Steering Committee to ensure the program is successful in its overarching goal of
understanding immune responses to SARS-CoV-2.